Examining reproductive and sexual health during the transition to adulthood

Project Abstract
Emerging adults attending community college are an underserved population at risk for poor sexual health
outcomes. Compared to students at 4-year institutions, community college students are more likely to
experience unintended pregnancy and STIs and are less likely to have access to comprehensive sexual health
resources. Additionally, emerging adults in this population are voracious and adept media consumers and
producers, and media have an important influence on emerging adults’ relationships and sexual health.
Community college students make up almost half of the college population, but relatively little research has
focused on their sexual health and media use, and to our knowledge no research has done so longitudinally
across emerging adulthood. As part of R01HD099134 (PI: Scull), we have recruited a large sample of young
community college students from across the U.S. (N=1647) to evaluate the effectiveness of a brief media
literacy education program for promoting sexual health. Measures on the baseline and 1-year follow-up
questionnaire include attitudes, normative beliefs, and behaviors related to sexual health and media. The
sample is diverse with respect to race-ethnicity, gender identity, and sexual orientation. As part of the proposed
project, we will leverage this existing sample to conduct a rigorous longitudinal cohort sequential design to
accomplish three Aims. In Aim 1, we will examine sexual health and quality of life trajectories of community
college students (total N=2247) across emerging adulthood (from age 18 to 24), including the moderating
influence of developmental contexts: gender and sexual identity, education, employment, relationships,
housing, health, and socio-structural barriers. In Aim 2, we will conduct the first longitudinal examination of
the reciprocal relationship between media use and sexual health across emerging adulthood with attention to
how critical media message processing may moderate this relationship and protect emerging adults from
harmful media influence. Finally, in Aim 3, we propose an innovative mixed methods design with purposive
sampling and multiple points of qualitative and quantitative data integration to better understand how
community colleges can create more inclusive and affirming environments to support the sexual health of
sexual and gender minority youth (SGMY). We will use quantitative data on community college resource
availability and quality, conduct in-depth interviews with 30 diverse SGMY, and utilize member checking to
contribute to validity of our results. An advisory panel of community college administrators will review
recruitment and data collection protocols, assist with efficient study dissemination, and form the beginnings of
a network of key stakeholders invested in promoting the sexual health of community college students. Findings
from this study will inform college resources and policies – beginning the process of enacting structural change
to better meet the sexual health needs of the rising generation of diverse emerging adults attending community
college across the U.S.

Public health relevance
Project Narrative Community college students make up almost half of the college population, but very little research has focused specifically on this underserved group, and no research has examined their sexual health across emerging adulthood—a critical period during which the achievement of vocational, relational, and identity development milestones are intertwined with sexual decision making. We propose a project to 1) conduct the first longitudinal investigation of media use, sexual health, and quality of life of community college students across emerging adulthood—helping to expand theory and identify the most pressing directions for future programming— and 2) conduct a mixed methods study to better understand how community colleges can create more inclusive and affirming environments to support the sexual health of sexual and gender minority youth. Together, with an advisory panel of community college stakeholders, we will disseminate findings to research communities and decision makers at community colleges across the U.S., to help them better address the needs of the rising generation of emerging adults attending community college.